Alleviation of ER stress as a translational strategy to curb ocular viral infections

Infection-associated blindness caused by herpesviruses is a leading cause of vision loss in the United States.
Frontline therapies include the use of nucleoside analogs such as acyclovir which inhibit the viral thymidine
kinase to restrict viral DNA replication. However, emergence of drug resistance and lack of strong corneal
bioavailability have made it an urgent priority to develop alternative therapeutics. We have recently discovered
a new mechanism through which herpesviruses, exemplified by herpes simplex virus type-1 (HSV-1),
propagate in the corneal epithelium. We have shown that endoplasmic reticulum (ER)-localized host protein
cyclic adenosine 3′,5′-monophosphate (cAMP) response element-binding protein 3 (CREB3) is essential to
HSV-1 replication. Our findings shift the current understanding that CREB3 is only a cellular homolog of HSV-1
VP16. We showed that it is an important pro-viral factor that can be exploited to generate novel therapeutics
against HSV infections. We for the first time showed that its modulation via a chemical chaperone 4-
phenylbutyrate sodium (Na-PBA), can alleviate, ER stress, reduce CREB3 expression and inhibit viral
replication. PBA is currently approved to treat urea cycle disorder. Our translational results are supported by
strong in vivo murine data that suggests antiviral efficacy and topical dosage safety of Na-PBA. Due to the high
sodium burden associated with Na-PBA administration, its unpalatability, and inability to penetrate sufficiently
through corneal epithelium upon topical administration, we have developed various sodium-free PBA
nanoformulations to overcome limitations associated with oral and topical delivery of Na-PBA. The purpose of
this R24 application is to generate preclinical data in two animal models that support an IND application for
repurposing PBA to treat ocular HSV infection. This will be achieved via 3 well thought, exhaustive specific
aims. In the first aim, we will evaluate dose-dependent pharmacokinetics, and safety of orally and topically
delivered Na-PBA solution and various sodium-free PBA nanoformulations. Furthermore, we will also
determine oral and topical, and oral antiviral efficacy of Na-PBA and sodium-free PBA nanoformulations in
murine models of ocular HSV-1 infection. The second aim will use the most effective oral and topical
formulation(s) and test their safety, PK, and efficacy in guinea pig and rabbit models of primary and reactivated
ocular HSV-1 infection. Finally aim 3, we will investigate the potential of Na-PBA and sodium-free PBA
formulations to synergize with existing antiviral therapies to determine their potential as an add-on modality to
the existing treatment. The latter is likely and significant since PBA is a rare drug that works via alleviating ER
stress and aiding the host cell’s response to viral infection, and thereby reducing the chance for emergence
of viral resistance. We have assembled a multidisciplinary team including scientists, clinicians, drug
development and translation experts who can help us navigate through requisite FDA guidelines. PBA has the
potential to become a safe and efficacious alternative to existing ocular antivirals very quickly.

Public health relevance
This application employs an integrative approach to rapid and efficient translation of our recent discovery that an already approved drug can be repurposed to treat vision loss originating from herpesvirus infection of the eye. Proposed preclinical studies will facilitate an IND application to the FDA for testing our new treatment.